Optimizing Syngeneic Mouse Models to Target Mutant p53

Optimizing Syngeneic Mouse Models to Target Mutant p53
Project Abstract
The tumor suppressor gene p53 is the guardian of the human genome. p53 is a transcription factor that
transactivates a battery of target genes in cells upon diverse stressors, including environmental carcinogens
and oncogene activation. Inherited mutations in the p53 coding sequence occur in ~80% of all families with Li-
Fraumeni syndrome (LFS), a rare autosomal dominant hereditary disorder characterized by a high-penetrance
predisposition to multiple types of cancers. Somatic mutation of the p53 coding sequence occurs in about half
of all cancers. Most alterations in the p53 coding sequence, either germline in LFS patients or somatic in
cancer tissues, are missense mutations in the DNA-binding domain that result in an oncogenic protein. Due to
its high mutation frequency and critical role in cancer initiation and progression, mutant p53 is a high-
priority target for the development of anticancer therapies. Several small molecules have been developed
to convert mutant p53 to a form that exhibits some wild-type properties (i.e., p53 reactivation). Such
compounds are in clinical trials, yet none of them have been approved by the FDA. There are several major
types of mouse models for cancer research, each with weaknesses and strengths: syngeneic, human cell line-
derived xenograft, patient-derived xenograft, genetically engineered, and carcinogen-induced. Most therapeutic
programs against mutant p53 use human cell line-derived xenograft, which is immunodeficient. Syngeneic
mouse models, also known as allograft tumor systems, consist of tumor tissues derived from the same genetic
background as a given mouse strain. Syngeneic mouse models with a functional immune system are superior
to human cell line-derived xenografts for immunotherapeutic development. Syngeneic mouse models are
instrumental in developing novel antitumor immunotherapies, yet there are no corresponding models to most
p53 hotspot mutations found in human cancers. In this project, we will study the potential vulnerability of
top somatic human p53 hotspot mutants using optimized syngeneic mouse models. Specifically, we will
knock the top ten human p53 hotspot mutations into representative syngeneic mouse tumor cell lines. We will
test monoclonal antibodies and vaccines targeting the p53 mutants in mice with a functional immune system.
This work will define new uses of syngeneic mouse cell lines and test approaches to validate and credential
the optimized p53 experimental model systems. Our findings will have broad and far-reaching translational
significance by addressing the unmet clinical need for precision medicine against mutant p53.

Public health relevance
Project Narrative Despite decades of basic research and therapeutic development, p53 mutant proteins remain undruggable due to the lack of enzymatic activity and intracellular localization. There is a critical gap between existing mouse models and the translational research targeting mutant p53 in the era of immunotherapy. We will use the optimized syngeneic mouse models to develop precision cancer therapeutics against the top hotspot p53 mutants in immunocompetent systems.